The Family Bridge Program to Improve Communication and Navigation-Related Outcomes for Minority Children and Families: A Randomized Controlled Trial

Pediatric healthcare disparities in the United States (US) have been documented across many sites of care. Suboptimal patient-provider communication contributes to these disparities; this is compounded by mismatches between a family’s skills and resources and the complexity of the health system (such as health literacy and system navigation). Few interventions exist to address disparities related to communication and system navigation in the inpatient setting; given the established links to disparate clinical outcomes, such interventions are needed. To address this gap, the study team collaborated with parents/caregivers, staff, and providers to develop and pilot-test a novel program to improve navigation ability, communication, and hospital-to-home transition for a broad population of children and their families, The Family Bridge Program (FBP).
The FBP combines principles of effective patient navigation and communication coaching interventions into a brief and targeted inpatient program. It is designed for a broad population of low-income Black, Latino, Indigenous, and Asian children of color, is not disease-specific, is not limited to English-proficient families, and is less time-intensive than traditional navigation, to enable provision of support to more families. The FBP, delivered in-person by a trained lay navigator, includes: (1) hospital orientation; (2) unmet social needs screening (e.g., food insecurity); (3) parent communication preferences assessment, relayed to the medical team; (4) communication coaching for parents; (5) emotional support; (6) assistance with care coordination and logistics; and (7) a phone call 2 days post-discharge. Program elements are flexibly delivered based on parent need and interest.
In pilot testing, the program was feasible to deliver, acceptable to parents and providers, and significantly improved parent-reported system navigation ability. The current R01 proposes a two-site randomized controlled trial (RCT) of the effectiveness of FBP among 728 families of low-income Black, Latino, Indigenous, and Asian children. Enrolled families will be randomized 1:1 (stratified by site) to FBP or usual care plus written resources. The specific aims of the study are to (1) Adapt the FBP to a new site using a rigorous and replicable process, Socio-Technical Analysis, which will also result in an implementation guide for future adaptations; (2) Test the effect of the FBP on parent-reported system navigation ability, quality of hospital-to-home transition, diagnosis comprehension, observed communication quality, perceived stress and revisits; (3) Examine whether changes in parent-reported challenges and needs mediate program effects; and (4) Identify subgroups of parents among whom the FBP is more effective. The proposed RCT will use a rigorous design to test a feasible, innovative program to address a critical national issue. If effective, the Family Bridge Program would provide a scalable model for improving health care experiences and outcomes for families of low-income Black, Latino, Indigenous, and Asian children, including those with LEP.

Public health relevance
Pediatric healthcare disparities in the United States have been documented across many sites of care; patient-provider communication and the frequent mismatch between a family’s skills and resources and the healthcare system’s complexity (such as health literacy and system navigation) contribute to these disparities, yet few interventions exist to address them. This project will test the effectiveness of the Family Bridge Program, a novel intervention combining principles of effective patient navigation and communication coaching into a brief and targeted inpatient program, on family-centered outcomes including system navigation ability, hospital-to-home transition, comprehension, and observed communication quality. If found effective, the Family Bridge Program would provide a scalable model for addressing disparities in healthcare experiences and outcomes for families of low-income Black, Latino, Indigenous, and Asian children, including those with limited English proficiency.